Deciphering molecular details of cellular sugar transport and their roles in disease

PROJECT SUMMARY/ABSTRACT
Sugars, in particular glucose, are bioenergetic molecules involved in a broad range of essential cellular processes. These
metabolites, and their derivatives, are essential intermediates in glycolytic pathways leading to the production of ATP and
are further used in the glycosylation of proteins and other macromolecules as part of the biosynthetic-secretory pathway.
In humans, glucose is absorbed in the small intestine by enterocytes and delivered to the bloodstream. Blood glucose
concentrations are tightly regulated by hormonal control and conserved reabsorption mechanisms in the kidneys. Secondary
active transporters facilitate these absorption/reabsorption processes as well as the exclusive delivery of activated sugar
molecules to the ER and Golgi. Disturbances in these functions are associated with numerous human disorders, such as type
II diabetes. It is, therefore, a critical objective of biomedical research to understand the structural intricacies of these dynamic
transporters.
During my 15-year tenure as an independent investigator, my lab has produced a number of experimental firsts—the first
crystal structure of a sodium glucose transporter, the first crystal structure of the Voltage Dependent Anion Channel,
and the firsts to use these coordinates for their biochemical and biophysical characterization. The last five years have been
extremely fruitful for my lab. We have complimented these original structures with new structures in distinct conformations
and incorporated their biophysical characterization in effort to elucidate their transport mechanisms. These findings have
direct implications to our collective understanding of associated diseases and aid in drug development. This has been made
possible due to my long-standing R01 funded by NIGMS that is currently in its 14th year. Additionally, I was recently
awarded a new R01 that aims to elucidate the structural basis of transport for Nucleotide Sugar Transporters. These sources
of NIGMS funding have allowed my lab to answer fundamental questions regarding sugar transport and cellular processing.
This current proposal embodies the spirit of the MIRA funding scheme by allowing me to tackle bigger questions that are
frequently referred to as `Higher-Risk' or `Ambitious Science', but that are the results every scientist truly dreams of
acquiring. Elucidating the structure-function relationship of membrane transporters is particularly risky and requires a long-
term commitment and flexibility to explore different directions of research and methodologies and developing new
approaches. The stability and flexibility incorporated into the MIRA allows us to do exactly that: try new exploratory
research, which will not only determine structures of human transporters that are direct pharmaceutical targets, but also
delineate their mechanism of transport that will clearly be applicable to many other transporters in general.

Public health relevance
PROJECT NARRATIVE Secondary active transporters are essential components of cellular physiology. In humans, they are implicated in numerous diseases and are considered targets of active pharmaceutical interest. We aim to structurally resolve human sugar transporters with medical relevance in type II diabetes, microbial infections, and other conditions related to sugar transport and metabolism. These structural studies will be complemented using spectroscopy, advanced X-ray scattering and Molecular Dynamics simulations in an effort to elucidate the molecular mechanisms of sugar transporter.